Mechanisms of Axonal Sprouting and Recovery in Intracerebral Hemorrhage

DESCRIPTION (provided by applicant): Stroke is the leading cause of adult disability. Stroke is produced both by direct blockade of blood flow and by hemorrhage. Intracerebral hemorrhage is the second leading cause of stroke. Intracerebral hemorrhage (ICH) has even less proportionate recovery than non-hemorrhagic stroke. However, in ICH there is a limited process of initial recovery and regaining of lost brain function. The mechanisms of functional recovery in ICH have not been studied. This application will determine the mechanisms for the formation of new connections and recovery in the brain after ICH. In non-hemorrhagic stroke, new connections are formed in the first month after the stroke, a process termed post-stroke axonal sprouting. The PI on this application proposal and other labs have identified the molecular mechanisms for axonal sprouting after stroke, and the association of axonal sprouting with functional recovery. The proposed studies will use newly developed techniques to identify the new patterns of connections that form in the motor system after ICH, the gene systems that mediate this axonal sprouting, and the causal link between axonal sprouting and functional recovery mediated through these gene systems, so as to determine molecules that may serve as therapeutic targets for neural repair in this disease. PUBLIC HEALTH RELEVANCE: Intracerebral hemorrhage is the second leading cause of stroke in the United States, and the most severe cause of stroke-related disability. There have been no studies on the mechanisms of re-connection and repair in the brain after intracerebral hemorrhage. The studies in this application will determine how the brain reconnects after stroke, the molecules that mediate this reconnection, and begin to identify potential new repair therapies for this disease.

Public health relevance
Intracerebral hemorrhage is the second leading cause of stroke in the United States, and the most severe cause of stroke-related disability. There have been no studies on the mechanisms of re-connection and repair in the brain after intracerebral hemorrhage. The studies in this application will determine how the brain reconnects after stroke, the molecules that mediate this reconnection, and begin to identify potential new repair therapies for this disease.